Multi-ancestry genome-wide association studies of biliary tract cancer

PROJECT SUMMARY/ABSTRACT
Biliary tract cancers (BTC) include cancers of the bile ducts and gallbladder and they claim approximately
170,000 lives each year globally. BTC has a median overall survival of 4.5 months, increasing incidence,
and is estimated to be the sixth leading cause of cancer death in 2024. Due to its aggressive nature and
lack of efficacious treatments, prevention is of the utmost importance in preventing lives lost to this
disease. Currently, BTC etiology is poorly understood. Major lifestyle risk factors include obesity, diabetes,
gallstones, smoking tobacco, and alcohol intake, but it remains unclear if their associations with BTC risk
are causal. Previous genome-wide association studies (GWAS) suggested markedly high heritability, but
these studies were small, with <2,500 cases. We propose to significantly expand an ongoing GWAS of
BTC by leveraging data and biologic samples from 21 studies and biobanks throughout the world
including, conservatively,12,000 BTC cases and >700,000 controls. In Aim 1, we will assemble and
harmonize data from 21 studies. In Aim 2, we will perform GWAS for BTC and its subtypes within studies
and ancestral groups and combine the results with meta-analysis as appropriate to identify genetic
variants associated with BTC risk. In Aim 3 we will delineate potential causal associations of BTC risk
with the aforementioned BTC risk factors using two-sample Mendelian randomization methods. Study
instruments will be derived from existing GWAS conducted for these risk factors. These analyses will
allow us to identify genetic risk factors for BTC and provide the most robust evaluation of potential causal
associations of lifestyle risk factors with BTC risk to date, directly supporting BTC primary and secondary
prevention.
1

Public health relevance
PROJECT NARRATIVE Biliary tract cancer is an aggressive malignancy, and its incidence is increasing internationally yet its etiology remains largely unknown. We propose a large study to identify BTC genetic risk variants and evaluate potential causal associations of lifestyle risk factors with BTC. 1